DUOX1 in fibroblast-macrophage cross-talk in pulmonary fibrosis

PROJECT SUMMARY
Idiopathic pulmonary fibrosis (IPF) is a progressive, deadly disease characterized by the accumulation of scar
tissue in the lung. Oxidative stress has frequently been implicated in IPF, but the underlying mechanisms through
which altered redox balance contribute to IPF pathogenesis are not fully understood. Recent observations by us
and others indicated that the NADPH oxidase homolog DUOX1, normally primarily present in the respiratory
epithelium with a main function in mucosal host defense, is increased in lung tissues of humans with IPF and
mice with bleomycin-induced pulmonary fibrosis, and largely within non-epithelial cells likely including pulmonary
fibroblasts and macrophages. Preliminary findings indicate that DUOX1 also contributes to experimentally-
induced fibrosis, especially in aging mice. However, it is still unclear which lung cells are involved in increased
DUOX1 expression and its profibrotic functions. In this exploratory grant, we will aim to identify the cellular source
of DUOX1 expression during fibrosis, and use cell-specific deletion of DUOX1 to address e.g. fibroblast- or
macrophage-specific roles of DUOX1 in pulmonary fibrosis (Specific Aim 1). In an effort to understand the
mechanisms by which DUOX1 may promote fibrosis, we identified several DUOX1-interacting proteins, including
IGF2R and S100A8/A9, which have been previously linked to fibroblast activation and/or myofibroblast
differentiation. Based on this, we will assess interactions of DUOX1 with these and other proteins in normal or
fibrotic human and mouse lung tissues, and in fibroblasts or macrophages isolated from these tissues. We will
also explore the hypothesis that DUOX1 regulates these proteins functionally by oxidative mechanisms, in
isolated fibroblasts or macrophages, by either overexpressing or deleting DUOX1 (Specific Aim 2). Successful
accomplishment of these aims will yield novel functional aspects of DUOX1 in macrophage or fibroblast biology,
and their contributions to IPF pathology.

Public health relevance
PROJECT NARRATIVE This project will address the mechanisms underlying the development of diopathic pulmonary fibrosis (IPF), a progressive, devastating disease characterized by the accumulation of scar tissue in the lung, for which no adequate cure(s) exist today. Oxidative stress has frequently been implicated in IPF, and our preliminary work has identified the NADPH oxidase enzyme DUOX1 as a potential source of such oxidative stress. In this exploratory grant, we will aim to identify the cellular source of DUOX1 expression during experimentally-induced fibrosis, and use cell-specific deletion of DUOX1 to address e.g. fibroblast- or macrophage-specific roles of DUOX1 in pulmonary fibrosis. To understand the mechanisms by which DUOX1 may promote fibrosis, we will perform functional studies in isolated fibroblast or macrophages, and assess proteins that interact directly with DUOX1 and form a major target for its activity. Successful accomplishment of these aims will yield novel functional insight into DUOX1 functions in macrophage or fibroblast biology and its contributions to IPF pathology.